DEVELOPMENTAL GENETICS OF CAENORHABDITIS ELEGANS

The overall goal of the proposed research is to further the art of genetic analysis of the free-living nematode Caenorhabditis elegans, a model organism for studying the genetic basis of animal development, chosen because of its limited size and cell number and its suitability for genetic manipulation. An understanding of the genetic basis of development may well be fundamental to much of medicine and may ultimately contribute importnat information to a range of problems from congenital defencts to senescence. Mor specific objectives are: first, to identify new chromosome rearrangements in C. elegans that can be used to balance recessive lethal and sterile mutations and deficiencies; second, to generate sets of overlapping deficiencies that can be used to classify to subsegments of the genetic map newly identified lethal and sterile mutations; third, to identify and characterize spermatogenesis defective and oocyte defective mutants; fourth, to identify new chromosome duplications; fifth, to make use of segmental aneuploids and two-dimensional gel electrophoresis to identify regions of the genome responsible for proucing specific gene products; and sixth, to analyze the sexual phenotypes of sex-specific cells and their lineages in animals made intersexual by a critical X-to-autosome ration.